Vision in Natural Tasks

Summary/Abstract
In the context of natural behavior, humans make continuous sequences of sensory-motor decisions to
satisfy current behavioral goals, and vision must provide the information needed to achieve those goals. The
proposed work examines gaze and walking decisions in locomotion in outdoor environments, taking advantage
of our novel system for measuring combined eye and body movements in these contexts. Currently we have
only limited understanding of the constituent tasks in natural locomotion, or the requisite information, and the
proposal attempts to specify these.
in the context of natural gait, the patterns of optic flow are unexpectedly complex, raising questions about
its role. The patterns of motion on the retina during locomotion depend critically on both eye and body motion,
and these in turn depend on behavioral goals. Our first Aim is therefore to comprehensively describe the statistics
of retinal motion patterns in a variety of terrains and task contexts. We will measure binocular eye and body
movements while walking in outdoor terrains of varying roughness, crossing a busy intersection, and making
coffee. These contexts will induce different gaze patterns. We will provide a comprehensive description of the
motion stimulus in natural locomotion and help separate out self-motion signals from externally generated
motion. These data will allow a more precise specification of the response patterns in cortical motion sensitive
areas. Because of the complexity of natural motion patterns, we will re-examine the influence of optic flow on
walking direction in a virtual reality environment and test alternative explanations for the role of flow.
A central task in walking is foot placement, and we will focus on identifying the image properties that
make a good foothold. Stereo, structure from motion, and spatial image structure are all likely contenders. We
directly investigate the role of stereo in foothold selection by examining gait patterns in stereo-deficient subjects
in terrains with varying degrees of roughness. Using a different strategy, we will attempt to predict gaze locations
and footholds in rough terrain using convolution neural nets (CNN’s) to identify potential search templates for
footholds in rough terrain. We will describe fixation patterns from crosswalk and sidewalk navigation and attempt
to make inferences about their purpose, and use Modular Inverse Reinforcement Learning (MIRL) to predict
direction decisions and decompose the behavior into sub-tasks.
The collection of integrated gaze, body kinematics, and scene images in a range of natural environments
is innovative, as little comparable data exists The work will be strengthened by the investigation of stereo-
deficient subjects for whom there is almost no integrated eye and body data. Since much of the work in robotics
has no visual input at all this should help in development of visual guidance for robots and also help better define
the necessary information for individuals with impaired vision. The data set will be made publicly available.

Public health relevance
Project Narrative The central goal of this work is to understand vision in its natural context. This is very important information in order to devise suitable vision aids and rehabilitation strategies for individuals with visual impairments, and it is becoming increasingly accessible because of developments in technology for monitoring eye and body movements. The proposed work examines gaze and walking decisions in locomotion in outdoor environments, taking advantage of our novel system for measuring combined eye and body movements in these contexts. Currently we have only limited understanding of the constituent tasks and requisite information in natural locomotion, and the proposal attempts to specify these. The collection of integrated gaze, body kinematics, and scene images in a range of natural environments is innovative, as little comparable data exists. The work will be strengthened by the investigation of stereo-deficient subjects for whom there is almost no integrated eye and body data. Since much of the work in robotics has no visual input at all this should help in development of visual guidance for robots and also help better define the necessary information for individuals with impaired vision. The data set will be made publicly available.